Bridges to the Baccalaureate at Cal State LA

Abstract/Summary
California State University Los Angeles (Cal State LA), East Los Angeles College (ELAC), and Pasadena
City College (PCC) propose to deepen their collaboration to establish a T34 Bridge to the Baccalaureate (B2B)
Program. It is the mission of the B2B at Cal State LA to develop and make available to top biomedical PhD
programs the creativity and intellectual talents of our most motivated URM, disabled, and disadvantaged
undergraduates at ELAC and PCC; and to enrich the American biomedical research enterprise through their
participation. B2B Trainees will begin their training at ELAC and PCC; seamlessly transfer to and be integrated
into the Cal State LA Junior-Senior U-RISE Program to complete the baccalaureate; and excel as they earn
the PhD; establish high profile independent research careers; and assume leadership positions in science.
We have reverse-engineered a two-year training program from the characteristics of highly successful
PhD students at major research universities, hypothesizing that growth into excellence as a PhD student has
its roots in the freshman and sophomore experience. Talented freshmen motivated for careers in biomedical
research will be supported and nurtured through lower-division majors at PCC and ELAC, coupled with
concurrent year-round laboratory research training at Cal State LA, taking advantage of the strengths of each
institution: the strong and supportive didactic environment at ELAC and PCC, and the strong undergraduate
research tradition at Cal State LA. This powerful combination is designed to increase B2B Trainees’ research
skills; enhancing their academic background and achievement; exposing them to a range of biomedical
sciences and scientists at all career stages; and integrating them into the broader Southern California
biomedical research community. Coupling B2B to U-RISE provides continuity of training effort and enhances
Trainees’ post-BS entry into top PhD programs. Through the T34 mechanism we can support year-round multi-
year participation in undergraduate research, replacing off-campus part-time work with research participation at
Cal State LA. Distributing their time between academics at ELAC/PCC and research training at Cal State LA
during the academic year is possible because of the proximity of the three campuses.
The B2B at Cal State LA Program is composed of: 1) early and sustained participation in authentic year-
round mentored laboratory research; 2) a solid undergraduate curriculum enhanced by supplemental
instruction, and by attention to questioning; 3) workshops to enhance the curriculum; 4) improving the
Trainees’ scientific writing; 5) participation in an Annual Biomedical Research Retreat; 6) developmental
participation in seminars; 7) using support networks to enhance success; and 8) career advisement and career
awareness. We have experience, capacity, and achievements in developing minority talent for success in PhD
programs. In the past 15 years, 31 B2B alumni have earned the PhD and another 24 B2B alumni are currently
PhD students. Through the T34 B2B enhanced training, our three institutions can do significantly better.

Public health relevance
The proposed Bridge to the Baccalaureate at California State University, Los Angeles (B2B at Cal State LA) research training program will develop talented and motivated URM-, disadvantaged-, and disabled science students at East Los Angeles College and Pasadena City College for success in academics and research as they prepare for transfer to strong BS programs, and subsequently pursue PhD training in biomedical science disciplines. This will make available a broad range of intellectual perspectives to solve the nation’s biomedical research problems. The proposed B2B at Cal State LA Program is relevant to the mission of the NIGMS Division of Training, Workforce Development, and Diversity by contributing significantly to the training and development of a strong and diverse biomedical research workforce.